Strengthening Shared Decision-Making for Older Adults with Kidney Failure Considering Kidney Transplant

PROJECT SUMMARY / ABSTRACT
The goals of this K23 application are to support shared decision-making for older adults considering kidney
transplant evaluation and to facilitate Dr. Catherine Butler's transition to independence as a physician scientist
whose research focuses on making the transplant evaluation process more person-centered and equitable.
Kidney transplant can be a valuable treatment option for the growing number of older adults with kidney failure,
but because of their limited life expectancy and high burden of comorbidity, most will not receive a kidney.
Further, the transplant evaluation itself can be time-consuming, burdensome, and risky, especially for older
adults who are particularly vulnerable to the complications of aggressive screening and treatments. Our
preliminary work suggests that patients often have little understanding of what to expect from the transplant
evaluation and limited opportunity to shape their involvement. A process of shared decision-making could help
older adults to navigate the complex trade-offs and uncertainties involved in the kidney transplant evaluation.
We propose an integrated research agenda intended to strengthen shared decision-making around referral for
kidney transplant among older adults. First, we will conduct an interview-based qualitative study to elicit the
experiences and perspectives of older adults with kidney failure related to the transplant evaluation process
along with their family members and clinicians (Aim 1). Second, we will describe the duration and likelihood of
completing discrete steps in the transplant process for a large national cohort of patients with kidney failure
(Aim 2). Finally, informed by these first two aims, we will adapt and pilot-test a communication tool to support
shared decision-making around referral for transplant among older adults with kidney failure (Aim 3).
During the award period, Dr. Butler will build upon her background in bioethics and early experience in
qualitative and epidemiologic research to acquire new expertise in the use of applied qualitative methods,
design and conduct of cohort studies, and development and testing of communication tools. This career
development plan will be supported by the exceptional research environment at the University of Washington,
including the Kidney Research Institute and the Seattle-Denver VA Center of Innovation. Dr. Butler's primary
mentor, Dr. Ann O'Hare, is an internationally recognized physician scientist whose research focuses on
complex care processes for older adults with kidney disease. Dr. Butler's co-mentors have complementary
expertise in transplant epidemiology (Dr. Peter Reese) and communication tool development and testing (Dr.
Margaret “Gretchen” Schwarze). The work proposed here will lay the foundation for a future trial to test the
communication tool developed during the award period and, more broadly, will identify multiple avenues to
improve upon the transplant evaluation process at both the individual- and systems-levels. Collectively, this
work will position Dr. Butler to become a successful independent physician scientist whose research focuses
on fostering a more person-centered and equitable approach to the kidney transplant evaluation process.

Public health relevance
PROJECT NARRATIVE Kidney transplant can be a valuable treatment option for older adults with kidney failure; however, the prerequisite physical and psychosocial evaluation process can entail substantial burdens for older adults and many will not ultimately receive a kidney. To ensure that the approach to care during this evaluation process aligns with the values and goals of individual patients, we propose a research agenda that will strengthen shared decision-making for older adults considering referral for kidney transplant evaluation. Together with an integrated career development plan, this work will also support Dr. Catherine Butler's transition to becoming an independent physician scientist whose research focuses on making the kidney transplant evaluation process more person-centered and equitable.